Investigating Early Social Communication Trajectories of Late Talking Toddlers to Best Predict Language Outcomes for the NIH TALK Initiative

ABSTRACT
The goal of the parent R01 MH121364 investigation is to validate the effectiveness of a new automated
online screening tool based on parent report—the Social Communication (SoCo) CheckUp—which
incorporates empirically-tested screening items for communication delay and autism spectrum disorder (ASD).
The parent investigation is recruiting 4,000 infants who join Baby Navigator by 9 months of age. All families of
children with a positive autism screen at each SoCo Checkup, and a comparison group with a negative screen,
are invited to upload a video home observation that is coded using the Systematic Observation of Red Flags of
ASD (SORF). The parent grant is addressing the following research aims: Aim 1. Study psychometric
features of the SoCo Checkup cut-off and composite to diagnostic outcome; Aim 2. Study the trajectories of the
SoCo surveillance and screening to predict severity of autism diagnostic features; and Aim 3. Construct a risk
algorithm based on multiple parameters to develop an efficient, cost-effective mobile screening application for
use in infants that is readily deployable in the general population. The expected outcomes of this validation study
will demonstrate the effectiveness of an online surveillance and screening system beginning in the first year of
life that will be ready for immediate, rapid, scalable, and sustainable deployment across the US.
In response to NOT-DC-23-005, this administrative supplement will build upon our previous research on late
talkers and capitalize on the evaluation of children recruited for the parent grant to contribute to elucidation of
early social communication trajectories and unique language outcomes of late talking children in this sample. Of
the children recruited and screened in the parent grant, 1,768 will be 2-4 years of age during the supplement
project period. We will invite 300 children to participate in the supplement follow-up evaluations at 2-4 years of
age. The evaluations in the parent grant will be enhanced by coding new early measures based on observation
of social communication and language (OSCL) and observation of responsive parenting strategies (ORPS) as
part of the supplement using the collected home observations from the parent grant. This supplement will
address the following research aims: Aim 1. To study associations among new measures coding the OSCL and
ORPS from the home observations and the collected measures in the parent grant—the SoCo CheckUp and
SORF from 9-24 months; Aim 2. To study trajectories of the SoCo CheckUp, SORF, OSCL, and ORPS from 9-
24 months in predicting new measures of language outcomes at 2-4 years of age; and Aim 3. To examine
sociocultural demographic indicators as predictors of social communication trajectories and language outcomes
of late talkers. The early social communication measures and sociocultural indicators together with these new
measures of language at 2-4 years will enhance data available to characterize differential trajectories to predict
language outcomes and improve our understanding of the developmental sequalae for late talking children.
Page 1 of 1

Public health relevance
PROJECT NARRATIVE The proposed administrative supplement will build upon our previous research on late talkers and capitalize on the evaluation of children recruited for the parent grant to elucidate early social communication trajectories and unique language outcomes of late talking children. Because delays in social communication are apparent long before language delays are evident, measures of early-developing social communication skills offer a viable solution for earlier detection of children with developmental delays and subsequent educational challenges. The early social communication measures and sociocultural indicators together with these new measures of language at 2-4 years will enhance data available to characterize differential trajectories to improve our understanding of the developmental sequalae for late talking children.